Moving and shaping neuronal lysosomes in Alzheimer's Disease

Abstract
This project will define mechanisms that coordinate late endosome and lysosome functions across the extreme
size and polarity of neurons. Although multiple proteins have been implicated in this process, there is a significant
lack of understanding concerning how the network of proteins that control of lysosome function is integrated in
support of the unique demands of neurons. This is a bottleneck to understanding the mechanisms whereby
variants in genes encoding lysosome proteins contribute to multiple neurodegenerative diseases. In particular,
this is a barrier to understanding the relevance of abnormal lysosome accumulations that occur within neurons
that contact amyloid plaques in Alzheimer’s disease as it results in a lack of tools to modulate neuronal
lysosomes for scientific and therapeutic purposes. Our proposed research will address these problems by
building on extensive preliminary data related to the JIP3 and JIP4 proteins (encoded by the MAPK8IP3 and
SPAG9 genes respectively). JIP3 and JIP4 control multiple aspects of lysosome function by acting as scaffolds
that link lysosomes to motors and signaling proteins in order to regulate their subcellular distribution as well as
the budding of vesicles from them. Our preliminary data indicates that there are major differences in the
regulatory mechanisms that control the subcellular activities of JIP3 and JIP4 in neurons. We now seek to
determine the basis for the compartmentalized differential activation of JIP3 and JIP4 and to use new insights
into JIP3 and JIP4 regulation as tools to test the lysosomal contributions to Alzheimer’s disease pathogenesis.
To this end, we will use experimentally tractable human cell lines to define fundamental relationships between
JIP3, JIP4 and their regulatory proteins along with assays in human iPSCs and neurons derived from them and
genetically modified mice to establish the physiological relevance of our discoveries. Through this research we
aim to achieve the following goals:
1. Define pathways that differentially regulate JIP3 and JIP4-dependent control of lysosome subcellular
distribution.
2. Determine mechanisms whereby JIP3 and JIP4 control signaling and vesicle budding events that control
the protein composition of lysosome membranes.
3. Establish the in vivo impacts of JIP3 and JIP4-dependent processes on neuronal lysosomes with a focus
on Alzheimer’s disease related proteins.

Public health relevance
Neurodegenerative diseases are linked to lysosome dysfunction, but effective therapies are hindered by insufficient knowledge of the regulatory mechanisms controlling lysosome activity in the central nervous system. Our research aims to identify these mechanisms through a focus on proteins that regulate lysosome subcellular distribution within neurons by acting as scaffolds that link lysosome to molecular motors. We seek to use new insights into the regulation of neuronal lysosomes to test contributions of abnormal neuronal lysosome transport to Alzheimer’s disease.